Targeting Senescent Macrophages to Improve Heart Failure Outcomes

PROJECT SUMMARY/ABSTRACT
Heart failure (HF) remains a leading cause of morbidity and mortality worldwide. Despite the availability of various
therapies, preventing the maladaptive changes associated with HF continues to be a challenge. This R01 project
will elucidate the mechanistic aspects of how cardiac tissue-resident macrophages (TRMs) contribute to adverse
remodeling in the heart during HF. Our long-term goal is to target innate immune response in the heart to pause
and even prevent HF progression. Over the past decade, the PI's lab and others have demonstrated that cardiac
TRMs play cardioprotective roles in various cardiac diseases and HF conditions. However, preliminary studies
on human failing hearts and mouse HF models showed that in HF conditions, cardiac TRMs transitioned into a
pathologically senescent state (SenTRM), which correlates with cardiomyocyte (CM) stress and inflammation.
Interestingly, this transition is reversible with interventions that can unload the failing heart, suggesting the
therapeutic significance of SenTRM modulation in HF. The central hypothesis is that macrophage senescence
promotes CM dysfunction in HF involving chronic inflammation and impaired clearance of CM debris, the
mechanisms of which will be dissected in the following three aims. Aim 1 will determine whether TRM
senescence contributes to CM inflammation through both the loss of steady-state TRMs and the rise of
senescent TRMs. Aim 2 will determine whether SenTRMs have an impaired clearance function, specifically their
role in removing CM mitochondrial debris—a key factor in heart function deterioration. Aim 3 will address the
upstream mechanisms leading to TRM senescence, focusing on whether blocking Interleukin-6 signal reverses
macrophage senescence. This project is conceptually and technically innovative, involving cutting-edge
single-nucleus profiling, human patient-derived cell-based models, and mouse genetic tools to test the
hypothesis and elucidate the underlying mechanisms of macrophage senescence in HF. The mechanistic
insights gained from these studies will enable the development of novel therapeutic strategies that specifically
target macrophage senescence to prevent adverse cardiac remodeling during HF. Thus, this project has a solid
translational impact, opening new avenues for improving treatment outcomes in patients with HF, an area of
high significance to NIH/NHLBI.

Public health relevance
PROJECT NARRATIVE Although therapies are available, heart failure remains a leading cause of morbidity and mortality worldwide. In patients with end-stage heart failure, their cardiac macrophages become senescent, which can be correlated with the adverse remodeling of the heart. Here, we will perform mechanistic studies to understand the detrimental impact of these senescent macrophages on heart muscles and impaired function, focusing on their roles in chronic inflammation and disrupted homeostasis. In the long term, reversing macrophage senescence can be a therapeutic strategy for improving heart failure outcomes.